LONGITUDINAL STUDY: ALCOHOLICS ANONYMOUS

APPLICANT'S ABSTRACT: Alcoholics Anonymous (AA) is the oldest and most widely used mutual-help program for alcohol-related problems, yet AA is also one of the least understood approaches for recovery from alcoholism. This K02 application describes a career development plan to enlarge the candidate's knowledge in psychopathology, psychopharmacology, and statistics for the purposes of expanding on, and initiating , programmatic longitudinal research on AA. Four career objectives are specified, and five mechanisms are outlined to achieve these goals. One mechanism, an AA-focused conference for senior scientists (R13), bridges career and research objectives and offers a forum to set priorities in AA research. Knowledge gains are instrumental for developing a more ecological understanding of AA, and for transitioning from a senior methodologist to an independent scientist. A cohort longitudinal study of AA (N=300) is proposed (R01), with participants recruited from community-based AA, outpatient, and inpatient settings. The overall aim of the study is to gain new knowledge about how people move into, through, and out of AA over time, and how their participation in AA predicts drinking and other drug use. Consideration of current psychopathology and illicit drug use represents a significant broadening of contemporary AA-related research, one that mirrors current changes in AA membership characteristics. Advanced statistical techniques for modeling AA attendance and involvement trajectories over a two-year period are proposed, analyses that will account for potentially moderating effects of perceived utility of specific AA-related beliefs and practices. Measurement of perceptions of AA utility is anticipated to offer radically new definitions of AA affiliation and disaffiliation, definitions based upon the extent that AA-related practices and beliefs are adopted (and why) rather than on AA meeting attendance per se. In addition, specific hypotheses in the core AA literature, such as the distinction between abstinence and sobriety, and how sobriety is achieved, will be tested. Study aims and career development activities are orchestrated to launch a career as an independent scientist, and to serve as a nexus for the emergent subdiscipline of AA-related research.